STAFF PRIORITY TIME HIGH PRESSURE XENON: PRODUCE HEAVY ATOM PROTEIN DERIVATIVES

It is now well established that xenon binds to numerous proteins upon moderate pressurization. We recorded significant changes in diffraction intensities from myoglobin crystals, for up to 5 minutes following depressurization from 10 atm of xenon gas. We therefor attempted to trap xenon in the binding site by quickly flash-cooling a myoglobin crystal after depressurization (~5 seconds). The resulting isomorphous difference Patterson map revealed the presence of a well-ordered xenon site indicating that this method may be useful for proteins having xenon off-rates similar or slower than myoglobin.